Cortical Dynamics Underlying Interactive Language Use

Project Summary/Abstract
This project will investigate the neural mechanisms underlying utterance planning in the service of spoken
interactions. We hypothesize that planning-related activity within specific cortical sites enables the rapid vocal
exchanges necessary for fluent human conversation. To test this hypothesis, we will identify planning regions
using electrocorticography (ECoG), a technique with sufficient temporal and spatial precision to localize
neural responses in subjects engaged in both controlled interactions and unstructured conversation. In
preliminary data, we found that activity within the inferior frontal gyrus (IFG; containing Broca’s region) is often
tied to utterance planning. We will characterize ECoG responses by isolating both the linguistic processing
and phonological output buffer (i.e., working memory) components of these responses. We will then determine
the importance of planning-related activity by examining behavioral effects that result from complementary
reversible cortical perturbations.
In Aim 1, we will use ECoG to test our hypothesis that specific cortical sites are involved in speech-selective
motor planning in both controlled interactions (i.e., a question-answer paradigm) as well as natural,
ethologically-relevant conversation.
In Aim 2, we will dissect utterance planning into its component parts using two different approaches: (1) a
‘command-response’ paradigm with increasing relevance to speech (as opposed to other motor acts) to
determine the degree to which these responses can be characterized as linguistic processing and (2) a
variable delay picture naming task to isolate the phonological output buffering component of the observed
planning activity.
In Aim 3, we will assess the necessity of planning-related activity for vocal interactions by measuring the
behavioral deficits that occur following transient perturbations of planning regions. Direct cortical stimulation
will be used to disrupt planning activity with high temporal precision. Mild focal brain surface cooling will be
used as a complementary method of modulating the temporal dynamics of planning activity.
From our studies, we will investigate the cortical network enabling vocal interactions to better understand
the neural mechanisms underlying turn-taking with the broader goal of informing future therapeutic
interventions designed to address the clinical conditions affecting human social language use.

Public health relevance
Project Narrative We will investigate the planning-related mechanisms that enable human spoken interactions by measuring and manipulating cortical activity during vocal exchanges. The proposed research is relevant to the NIH's mission to contribute to the body of knowledge needed to help those who experience communication disorders.